HIV Prevention Conference

The National HIV Prevention Conference (NHPC) is the preeminent conference for scientists, public health officials, community workers, clinicians, and persons living with HIV from a wide variety of organizations to share their expertise and ultimately prevent infections, strengthen care and reduce disparities.